PEARL 2.0: The impact of the Ending the HIV Epidemic initiative and risk factor interventions on the projected multimorbidity burden and healthcare costs for people aging with HIV in the United States

PROJECT SUMMARY
Within the next decade, nearly 1 million people aging with HIV (PAH) using antiretroviral therapy (ART) in the
United States (US) will experience multi-decade life expectancy. The goal of this project is to build a suite of
modules to further the ProjEcting Age, multimoRbidity and poLypharmacy (PEARL) computer simulation model’s
capacity to inform clinical program and policy decision-making and resource allocation in governmental and
private healthcare systems in efforts meet the future needs of caring for PAH.
The Ending the HIV Epidemic (EHE) efforts will undoubtedly re-shape the age distributions of Black/African
American (AA), Hispanic, and white PAH within sex-and-HIV acquisition risk groups. Projections under various
scenarios of EHE goal attainment strategies within these subgroups are needed to answer the question: “How
will EHE efforts impact the number of older PAH (who need clinical care) over the next two decades?” As PAH
experience a greater burden of multimorbidity than people without HIV, and disparities persist within PAH
subgroups, clinical program and policy decision-makers need to know: “Can reductions in prominent risk factors
reduce future multimorbidity in PAH in the US?” Simulating reductions in prominent risk factors, such as smoking
and obesity, and estimating the impact on future multimorbidity will provide data where none exist. Finally, by
investigating the question “What are the future healthcare costs for caring for PAH in the US over the next 2
decades?” clinical directors, health systems and state and federal policy decision-makers can prepare for future
health care needs and allocation of resources.
The established PEARL modeling team will (a) collaborate closely with Johns Hopkins HIV Epidemic Economic
Model (JHEEM) team to construct a module to simulate the impact of EHE efforts, (b) continue their beneficial
partnership with the North American AIDS Cohort Collaboration on Research and Design (NA-ACCORD) to
construct a comorbidities prevention module, and (c) construct a costing module to achieve the following among
15 PAH subgroups using ART in the US through 2040:
AIM 1: To assess the impact of EHE goals on the projected number and age distribution.
AIM 2: To project the impact of reducing prominent risk factors on future multimorbidity burden.
AIM 3: To estimate the cost effectiveness of interventions to reduce risk factors and project HIV- and non-HIV-
related healthcare costs.
The proposed aims align with the research priorities of the 2021-25 Trans-NIH Plan for HIV and HIV-Related
Research and include Multidisciplinary Studies of HIV/AIDS and Aging (PAR-21-068) priority outcomes. Findings
will provide key HIV epidemiologic and health services data within 15 PAH subgroups to guide clinical programs
and informing healthcare resource allocations to ultimately improve the health of PAH in the US.

Public health relevance
PROJECT NARRATIVE People aging with HIV (PAH) have an increased burden of multimorbidity. This research will use PEARL, an agent-based simulation model of Black/African American (AA), Hispanic, and white PAH within 5 sex-and-HIV acquisition risk groups, to project the following through the year 2040: 1) the number of older PAH in the United States under various scenarios of progress towards Ending the HIV Epidemic goals; 2) the potential benefit of simulated reductions in prominent risk factors (namely, smoking cessation and obesity 24 months after ART initiation) on future multimorbidity; and 3) the projected HIV-related and non-HIV-related healthcare costs among PAH. This research will inform clinical program and policy decision-making to improve the health of PAH in the United States.